High-Throughput Sequencing Instrument for Stanford Cancer Center

DESCRIPTION (provided by applicant): This proposal requests funds to purchase an Illumina Genome Analyzer II (GA II) as part of ongoing efforts to advance biomedical research at Stanford University. The proposed High-Throughput Sequencing (HTS) instrument will be placed in the Stanford Functional Genomics Facility (SFGF) within the School of Medicine and be a HTS resource for the Stanford Cancer Center. Since SFGF is a service center, the entire community of NIH funded researchers at Stanford will have access to the technology provide by the GA II. The facility presently offers expertise, support, and services for genomics and proteomics research utilizing microarray technologies. As many investigators are currently turning to HTS as the gold standard for functional genomics studies, it is critical that a shared resource be available so that the pioneering research pursued here continues. The HTS capabilities of the GA II will give NIH funded researchers at Stanford University the ability to further understand how our genetic code affects human health and disease. PUBLIC HEALTH RELEVANCE: The requested high-throughput sequencing (HTS) instrument will be used to monitor and investigate biological molecules utilized by the cell. Knowledge of how these molecules function will give us a better understanding of their role in human health and disease.